Preventing Alcohol Exposed Pregnancy among Urban Native Young Women During the COVID-19 Pandemic

The devastating impact of COVID-19 on American Indian and Alaska Native (AIAN) communities has been
well-documented, with substantial focus on reservation communities, often rural and remote. However, more
than 72% of AIANs reside in urban settings, a majority of the racial group, but a small fraction – often less than
1% - of most urban communities. Many urban AIANs are tightly connected to tribal communities and cultural
practices, commonly traveling between urban areas and reservations to participate in family events or
important cultural celebrations and ceremonies. However, this group is likely to experience different cultural,
social, and economic impacts of the pandemic compared to those living in reservation settings. Those
differences are likely critical to alcohol-exposed pregnancy (AEP) risk. Early data in the general population
indicate increased alcohol use by youth, and decreased access to effective contraception among women. The
combination is likely to increase risk of AEP, and for urban AIAN young women – often with limited local
resources – that risk may be especially elevated. Yet, as research efforts scramble to monitor risk of the most
vulnerable in a pandemic, this demographic often becomes invisible. We know little about the impact of
COVID-19, the changes in alcohol use, sexual activity, or contraceptive use to assess risk among urban
AIANs. Similarly, we know little about the way in which these young women are able to find resilience and
strength in their communities to overcome the hardships presented by the pandemic or to engage in the
promise of vaccines. Our project, Native WYSE CHOICES, uses a randomized trial to evaluate a culturally
appropriate AEP prevention program translated to a smartphone app for urban AIAN young women (ages 16-
20) nationally. With our research infrastructure in place, we have the opportunity to tap shifts in behaviors,
attitudes, and perceptions of urban AIAN young women, their families, and communities as they navigate the
changing dynamics of the pandemic. We will (1) include additional survey measures with a national sample of
700 to capture the evolving pandemic in four main areas: (a) COVID-19 disease, risk exposure, and safety; (b)
social and economic impacts; (c) COVID-19 vaccine attitudes, experience, and status; and (d) cultural and
historical trauma impacts. To contextualize these findings, we will (2) conduct in-depth interviews with
participants purposively selected based on baseline survey responses. To maximize insights in the diversity of
experience of the pandemic and gain timely, in-the-moment, insights, we will recruit and interview young
women from our RCT sample (n=32) over 2 years. We will also interview selected participants (n=8) at regular
intervals over 2 years to capture their experiences longitudinally as circumstances of the pandemic shift. With
this qualitative design – i.e. cross-sectional insights complemented by a longitudinal view of urban AIAN young
women’s journey through the changing circumstances – we will be able to integrate our statistical findings
within an agile interpretive frame.

Public health relevance
The devastating impact of COVID-19 on American Indian and Alaska Native (AIAN) reservation communities has been well documented; however, more than 72% of AIANs reside in urban settings. Increased alcohol use and decreased access to effective contraception during the pandemic may mean an increased risk of alcohol exposed pregnancy (AEP) for urban AIAN young women. We will investigate the impact of COVID-19 on AEP risk for these young women nationally, and also the way in which they are able to find resilience and strength to overcome the hardships presented by the pandemic and to engage in the promise of vaccines.